Deer Mice as Tools for Infectious Disease Research

DESCRIPTION (provided by applicant): Deer mice are the principal reservoir hosts of Sin Nombre virus, which causes the great majority of hantavirus cardiopulmonary syndrome cases in North America. Unlike human infections, which are fatal in about a third of the cases, infected deer mice do no exhibit symptoms of disease and remain otherwise healthy but persistently infected, probably for life. This project has focused on understanding the immunological events that lead to persistent infection without disease. Our efforts have demonstrated that an anti-inflammatory immune response appears to predominate at persistence and this response likely limits pathology, but also compromises viral clearance. Andes virus also infects deer mice; however, it is cleared without disease. The project will continue to examine how SNV evades the host response and why Andes virus is cleared by focusing on the genetic, molecular and cellular events during the host response to these viruses.

Public health relevance
Hantaviruses can cause fatal diseases in humans, including hantavirus cardiopulmonary syndrome (HCPS). Sin Nombre virus, is hosted by the deer mouse (Peromyscus maniculatus) and causes most HCPS cases in North American, while Andes virus, hosted by the long-tailed pygmy rice rat (Oligoryzomys longicaudatus), causes most HCPS cases in South America. This project will examine how deer mice fail to clear Sin Nombre virus but clear Andes virus.